Myogenic Mechanisms of Craniofacial Skeletal Muscle Regeneration

ABSTRACT
This application is for a Mentored Clinical Scientist Research Career Development Award (K08) for Dr. Lauren
Katz. She is currently conducting research on craniofacial skeletal muscle and has observed that this muscle
type has a unique regenerative program compared to muscles of the limb and trunk. This K08 will enhance Dr.
Katz's ability to 1) become an expert in craniofacial muscle stem cells and regeneration, 2) conduct basic
science research at the highest level in a tissue rarely studied, 3) acquire cutting-edge skills in stem cell
techniques including single-cell RNA sequencing (scRNA-seq) and ex vivo cell transplantation, 4) gain skills in
proposal development, manuscript preparation, and data presentation, and 5) develop a high-quality
independent research program that will allow for collaborative opportunities with scientists and clinicians from
across disciplines. To achieve these goals, Dr. Katz has devised a clear and focused training plan and has
identified individuals who are experts in the aforementioned disciplines. Her multidisciplinary mentoring team
consists of: Drs. James White (basic scientist, skeletal muscle regeneration and stem cells), William Maixner
(clinician-scientist, oral and craniofacial research), Shannon Wallet (basic scientist, oral and craniofacial
research), Elisabeth Barton (basic scientist, skeletal muscle regeneration), Kevin Byrd (clinician-scientist, oral
stem cells), Lyndon Cooper (clinician-scientist, oral stem cells), Eric Everett (basic scientist, oral biology),
Jimena Giudice (basic scientist, skeletal muscle research), and Simon Gregory (basic scientist, scRNA-seq).
There exists a clinical need to rebuild functional craniofacial muscle in patients suffering from certain diseases
(muscular dystrophy, hemifacial microsomia), facial trauma, and tumor resections. The lack of a
comprehensive investigation of the craniofacial musculature and its stem population has resulted in a poor
understanding of the regenerative capacity of this tissue when faced with disease or trauma. Our current
knowledge of skeletal muscles and their stem cell populations comes from the limb muscles; however, it is
known that distinct differences in embryological origin exist between muscles of the limb and those of the
craniofacial region. Therefore, the objectives of this study are to use injury models to elucidate the in vivo
regenerative capacity of craniofacial skeletal muscle and to perform deep phenotyping on isolated craniofacial
satellite cells to identify molecular targets specific to craniofacial muscle regeneration. Regenerative capacity
will be assessed using in vivo models of muscle regeneration and in vitro cellular function assays (Aim 1).
scRNA-seq and ex vivo stem cell transplantation will be utilized to identify craniofacial muscle-specific
regulators of myogenesis (Aim 2) and identified targets will be investigated using lentiviral vectors and
knockout models (Aim 3). Together, the K08 training and mentorship will enable Dr. Katz to transition into an
independent research career and become a leader in the field of craniofacial muscle regenerative medicine
and translational therapeutics.

Public health relevance
PROJECT NARRATIVE Craniofacial skeletal muscle is essential for basic life functions including chewing, swallowing, and speaking; therefore, understanding how this tissue regenerates in response to injury and disease will provide the basis for therapeutic advances in the treatment of craniofacial muscle diseases and disorders. Our group has demonstrated that craniofacial skeletal muscle has the ability to regenerate following damage, but to what extent remains unknown. The goal of this proposal is to comprehensively investigate the regenerative capacity of craniofacial muscle and its stem cell population to inform developments in treatment modalities for individuals suffering from craniofacial muscle injury or disease.